EVALUATION OF PATIENTS WITH HYPERLIPIDEMIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This protocol allows for systematic evaluation of patients with hyperlipoproteinemia and unusual forms of lipid transport abnormalities, including provisions for family screening.